Inclusion of sex and gender variables in musculoskeletal research and publications

Abstract
Sex and gender impact all areas of health, including musculoskeletal health. Examples of sex- and gender-
based differences in musculoskeletal health include risks for developing and treatment outcomes of
osteoporosis, osteoarthritis, and ACL injuries. However, these differences are not routinely considered,
assessed, or reported in published articles, as demonstrated in several recent reviews of the literature for
various musculoskeletal conditions. The lack of consideration and published data regarding sex- and gender-
based differences impacts the development of future research, improvement in healthcare professional
education, and ultimately the quality of care for men, women, and transgender patients.
We plan to assemble a group of researchers active in the area of sex and gender and the editorial staffs of the
major scientific journals in musculoskeletal medicine and surgery to review the current status of research
regarding the impacts of sex and gender. We will discuss the need to assure that these variables are
appropriately considered in published research and will also assess options and platforms through which to
communicate the importance of sex and gender as variables in musculoskeletal health and disease to
investigators and journal reviewers. The goals of this one-day meeting at the intersection of the goals of goals
of the NIH Office of Research on Women’s Health to advance research “to improve the fundamental
understanding of how sex and gender, among other critical factors, influence health and disease, and to
extend this knowledge to translational and clinical studies” and those of NIAMS to “support research into the
causes, treatment, and prevention of arthritis and musculoskeletal… diseases”.
At the end of the meeting, the deliverables will be to (i) develop plans to consistently assess for the appropriate
inclusion of sex and/or gender in published research, including evaluating the role for adopting SAGER or
similar guidelines, and to communicate this across journal platforms and to reviewers, ii) identify
communication strategies from journals to investigators about the roles of sex and gender and the expectations
for consideration and inclusion of these in submitted manuscripts across musculoskeletal conditions, and iii)
explore opportunities to work with researchers early in the study process to assure that sex and gender are
considered in research project development and plans for data analysis. The meeting symposia will be
published in a Journal of Bone and Joint Surgery supplement and shared with NIAMS.

Public health relevance
Project Narrative We plan to assemble a group of investigators and thought leaders in the area of sex and gender health and representatives from the editorial staffs of the major scientific publications in musculoskeletal medicine and surgery, to determine how to improve reporting/publishing of these important variables across musculoskeletal research. At the end of the meeting, the deliverables will be to (i) develop plans to consistently assess for the appropriate inclusion of sex and/or gender in published research, including evaluating the role for adopting SAGER or similar guidelines, and to communicate this across their platforms and to reviewers, ii) identify communication strategies from journals to investigators about the roles of sex and gender and the expectations for consideration and inclusion of these in submitted manuscripts across musculoskeletal conditions, and iii) explore opportunities to work with researchers early in the study process to assure that sex and gender are considered in research project development and plans for data analysis. The meeting symposia will be published in a Journal of Bone and Joint Surgery supplement and shared with NIAMS.